SBIR/STTR Technical Assistance Program Support

One of the goals of the Small Business Innovation Research (SBIR) and Small Business Technology Transfer (STTR) program is to “increase private sector commercialization of innovations developed through Federal SBIR/STTR R&D.” Reauthorization legislations have consistently emphasized this goal by requiring agencies to include as a review criterion the commercial potential of a proposed project. To help NIH SBIR/STTR awardees move their products into the marketplace, offers the following trans-NIH SBIR/STTR assistance programs: • Commercialization Assistance Program (CAP): Provides assistance with developing and implementing an appropriate business strategy that will help commercialize the products that have resulted from federally funded SBIR/STTR research projects. Slots for seventy five (75) NIH SBIR/STTR Phase II awardees are available each year. • Niche Assessment Program (NAP): Assesses if there are other applications or niches for the SBIR/STTR-developed technology and evaluates the market opportunities, needs and concerns of the end-users, and helps to discover new markets for possible entry. Slots for one hundred twenty five (125) NIH SBIR/STTR Phase I awardees are available each year. Information about these programs is available at http://grants.nih.gov/grants/funding/tap.htm.